Biological Sequence Quality Control and Organization

During the past year, we improved our software package VADR
(https://github.com/nawrockie/vadr) for viral sequence annotation
using models based on RefSeq annotation. VADR aligns complete input
sequences to their nearest RefSeq sequence and uses that alignment to
map the RefSeq annotation onto the input sequences. VADR is
used by GenBank to help annotate Norovirus, Dengue virus, SARS-CoV-2
and metazoan cytochrome C oxidase subunit 1 (COX1) protein-coding gene
sequences.

Most of the work in the past year has focused on the development of
models for Respiratory Syncytial Virus (RSV) and influenza virus
(types A, B, C, and D). Creation of these models motivated the
development enhancements to the VADR software for better handling of
RSV and influenza sequences. These enhancements include intron splice
site validation, extra unexpected sequence at the ends of input
sequences, and the ability for VADR to handle alternative coordinates
for features that have a diversity of start and stop codon
positions. Some of these features were included in the VADR 1.5
release in September of 2022, and the others will be included in the
next release of VADR in the coming months.